Spotting-free Nano-Oscillator Array for Quantification of Virion Displayed Membrane Protein Binding Kinetics

ABSTRACT
Transmembrane proteins, such as G-protein-coupled receptors (GPCRs), are critical for many cellular functions.
They are also the most popular drug targets for various diseases, including cancer. For both understanding
cellular functions and drug development, it is necessary to measure their binding activities with molecular ligands
and drug candidates. However, this remains a difficult task because of several key challenges: 1) Directly
measuring ligand interactions with native receptors on whole cells is greatly limited by low sensitivity and through
put. 2) Methods to extract and purify transmembrane proteins often results in the loss of their native
conformations, thereby resulting in dysfunction. 3) Extracted membrane proteins must be reconstituted in an
artificial membrane environment that is tedious to synthesize and study. 4) Small molecules comprise ~90% of
the current drugs, but their binding kinetics cannot be easily measured, often requiring indirect measurement
approaches. 5) Current approaches lack sufficient throughput to service the needs of typically large drug libraries.
This project aims to addresses these critical challenges with Spotting-Free Nano-Oscillator Array (SFNOA)
technology, for high throughput, label-free quantification of ligand binding kinetics to transmembrane proteins in
their native states. SFNOA achieves this feat by integrating several innovative technologies: 1) Virion displayed
transmembrane proteins (VirD) preserve their native conformation and function while avoiding the drawbacks of
extraction and reconstitution. 2) Nano-oscillator technology enables charge-sensitive plasmonic detection of
label-free binding, making it particularly suitable for small molecule ligand measurements. 3) Affinity encoded
multi-state DNA barcoding produces spotting-free sensor chips for multiplexed detection. 4) Plasmonic scattering
microscopy enables high resolution detection of nano-oscillators for high density measurement.
Each VirD is conjugated to a nano-oscillator, which oscillates under an alternating electric field. Upon binding of
ligands to the transmembrane proteins, the oscillation amplitude changes and is measured precisely by a
plasmonic imaging system, from which binding kinetics and affinity are quantified. Since the response signal
scales with charge changes instead of mass changes, this direct detection method is particularly advantageous
for small molecule ligands. Additionally, each VirD nano-oscillator is addressed with an affinity enhanced DNA
barcode, making them rapidly readable in parallel for multiplexed and high throughput analysis. To showcase
the significance and capabilities of SFNOA technology, small molecule drug interactions with various human
GPCRs displayed on the viral envelopes of human herpes simplex virus-1 (HSV-1) will be measured. The goal
of this fast-track STTR is to develop SFNOA for commercialization into a powerful high throughput platform for
studying ligand binding kinetics to membrane proteins in their native states. SFNOA technology proposes to
become a powerful new tool for high throughput study of membrane protein functions, minimizing missteps in
early-stage drug discovery and screening, and quickly validating new therapies for rapidly evolving diseases.

Public health relevance
PROJECT NARRATIVE Membrane proteins are responsible for many critical cellular functions, and represent the most important family of drug targets, but they are extremely difficult to study without extraction and purification, which often results in loss of native conformation and disfunction. Consequently, this project aims to overcome these major challenges through the development of Spotting-Free Nano-Oscillator Array technology, which directly measures in high throughput small molecule drug interactions with membrane proteins in their native conformations. The success of this project will lead to a powerful new tool for high throughput study of membrane protein functions, minimizing missteps in early-stage drug discovery and screening, and quickly validating new therapies for rapidly evolving diseases.